Vet-LIRN Network Capacity-Building Projects

Project Summary/Abstract Vet-LIRN Network Capacity-Building Projects PAR-18-604 Breathitt Veterinary Center (BVC) seeks funding to maintain the high level of Quality Management within the organization by purchasing new batteries for our Uninterrupted Power Supply. The UPS provides a bridge between normal electrical power and the generators that serve as back-up power for BVC. Power to equipment is maintained via a battery array that provides power when the electricity supply is interrupted or the voltage drops to an unacceptable level. Highly sensitive diagnostic equipment such as the LC/MS/MS and the ICP/MS in toxicology, the MALDI-TOF and SensiTitre in Bacteriology and the AU7500 and Quant5 Studio in Molecular Diagnostics have several steps to properly shut them down without losing data. The operation of these units are also sensitive to changes in voltage that would deteriorate sensitive electronic components. This could lead to unexplained failures and impact the accuracy of data. The quality of test results is of utmost importance to our clients and is the basis of our Quality System. These batteries are necessary to guarantee the most accurate results. The cost of updated batteries for the UPS is $52,000. BVC will accept partial funding of this project.

Public health relevance
Project Narrative Vet-LIRN Network Capacity-Building Projects PAR-18-604 Breathitt Veterinary Center (BVC) is one of two state veterinary diagnostic laboratories in Kentucky. BVC is AAVLD accredited for all species. BVC is located in Hopkinsville, Kentucky and is associated with Murray State University, in Murray, Kentucky, 60 miles distant. While Murray State University supports BVC by every means possible, there are certain aspects of the maintenance of a veterinary diagnostic laboratory that are unique to laboratories. BVC retains its own grounds and custodial staff, and network administrator on site. Administrative, faculty and technical staff conduct testing with a Quality Manager to scrutinize policies and work instructions. Maintaining the infrastructure required to operate a facility with the complexity of BVC is costly and demanding. One of the items that must be maintained to ensure that quality standards are upheld is the Uninterrupted Power Supply (UPS). This is a battery array that ensures many items in BVC never lose electric power. The UPS provides a bridge between normal electrical power and the generators that serve as back-up power for BVC. Servers on site at BVC and desktop computers together with computers that run testing equipment should never be subjected to voltage variations and electrical disturbances such as sudden loss of power. These variations can damage components and scramble data maintained on the computer system. Data loss could occur in addition to the damage caused to operating systems such as the USALIMS laboratory management system and the QUALTRAX quality management system. Equipment at BVC such as the LC-MS/MS and the ICP/MS in toxicology, the MALDI-TOF and SensiTitre in Bacteriology, the ABI 7500 and Quant Studio 5 in Molecular Diagnostics all are very sensitive to power disturbances such as voltage sag or frequency variations. Any of these disturbances can cause deterioration to sensitive electronic components resulting in unexplained failures and problems with system performance and loss of important testing data. Protection of these expensive and critical pieces of equipment is essential. The LC-MS/MS and ICP/MS are used to evaluate feed of all types for toxins of both chemical and biological origin. Mycotoxins, pesticides and ionophores can be detected in feed samples on the LC/MS/MS. The ICP/MS is used to identify heavy metals and elemental toxins. The MALDI-TOF is a specially programed MS used to identify some bacteria quickly and accurately. The SensiTitre is used for the Anti-Microbial Resistance project that LRN sponsors. The ABI-7500 and Quant Studio5 are used to identify biological threats in feed via real time polymerase chain reaction (rPCR). All of these are utilized on a daily basis for routine diagnostic testing as well. UPS also would maintain systems within the BioSafety Level 3 (BSL 3) suite. This area needs to stay prepared for foreign animal and emerging disease testing. African Swine Fever (ASF), African Horse Sickness (AHS), COVID-19, and Foot and Mouth Disease Virus (FMDV) are constant threats that would require use of the BSL 3. Avian Influenza (AI) testing would also be performed in the BSL 3 suite for the protection of the public and the staff. While this falls outside the Vet-LIRN scope of funding programs, it is important to remember that ASF, FMDV and AI all impact the food industry. UPS batteries are required to be replaced periodically to ensure the strength of the battery remains at full power. BVC requests funding to replace the current batteries. This request follows the Funding Opportunity Purpose 2. “Support … quality assurance processes… and support national capacity/capability development”. The cost of updated batteries for the UPS is $52,000. BVC will accept partial funding of this project. Protection of data, ensuring testing results are accurate and guarding the ability to ensure a safe and constant food supply are important parts of the Vet-LIRN mission.